The role of immune-responsive gene 1 and itaconate in atherosclerotic disease

SUMMARY
In atherosclerotic cardiovascular disease (ASCVD), chronic inflammation is a major risk factor that remains
unaddressed by currently approved therapies. Existing therapies aimed at curbing ASCVD target lipid metabolic
pathways, and many patients continue to be at high risk of cardiovascular disease including myocardial infarction
and stroke. Although inhibition of the pro-inflammatory cytokine interleukin (IL)-1β was shown in the CANTOS
trial to reduce adverse cardiovascular events, the concomitant increased risk of fatal infections hindered its
therapeutic viability. Therefore, narrowing the gap between metabolism and immune cell function to discern the
processes governing inflammation resolution in ASCVD—and why they fail with disease progression—is a major
challenge in the field. To that end, we have identified itaconate, a TCA cycle-derived metabolite produced by the
enzyme cis-aconitate decarboxylase (ACOD1/IRG1), as a driver of inflammation resolution in atherosclerosis.
Itaconate is induced during microbial infection, and harbors anti-microbial and immunomodulatory functions,
including inhibition of the NLRP3-inflammasome, IL-1β secretion and reactive oxygen production. These
inflammatory pathways contribute centrally to atherogenesis, yet the regulation of IRG1 and impact of itaconate
on plaque immune responses has yet to be studied. In this proposal, we aim to (i) determine the metabolic and
immune processes by which the IRG1-itaconate axis curbs inflammatory responses in atherosclerosis and (ii)
investigate the effects of itaconate and its derivatives on atherosclerosis-associated inflammatory responses in
vitro, and iii) test whether the cell-permeable itaconate derivative 4-octyl-itaconate can reduce plaque burden
and instability in mice. Our studies will use novel mouse models to track itaconate abundance in vivo and
innovative 3D human vascular explants to investigate therapeutic modulation of the IRG1-itaconate axis in
ASCVD. Collectively, these investigations will identify novel mechanisms of metabolic control of local and
systemic inflammation during atherosclerosis and provide a foundation for the design of targeted
immunometabolic therapies for ASCVD.

Public health relevance
NARRATIVE Cardiovascular disease remains the number one cause of death in the United States. Despite lipid-lowering therapy, many patients remain at high risk of a cardiovascular event, and inflammation has been identified as a major residual risk factor. Our proposal aims to identify metabolic pathways contributing to inflammation resolution in atherosclerotic plaque and why they fail with disease progression, with the ultimate goal of discovering novel therapeutic strategies for treatment of cardiovascular disease.